Modeling the impact of regulatory and splicing variants on cellular function in Alzheimer's disease

Alzheimer's disease (AD) is an age-related neurodegenerative disease characterized by progressive
cognitive decline and dementia. Despite more than fifty years of research, no cures exist and the
standard of treatment remains unsatisfactory. Genome wide association studies (GWAS)
indicate that AD risk reflects both highly penetrant rare variants as well as common
single nucleotide polymorphisms with small effect sizes. By overlapping GWAS and post-mortem
and myeloid cell expression analyses, we have identified common variants with expression and
splicing quantitative trait loci that may contribute to altered gene expression or alternative
splicing; however, demonstrating which risk loci are the causal contributors to disease risk
remains an intractable problem. Here, we will apply statistical approaches to prioritize putative
causal variants in AD-associated loci by incorporating expanded AD GWAS functional annotations,
single cell chromatin profiles and histone modification and microglia gene expression datasets. We
will then apply a human induced pluripotent stem cell (hiPSC)-based approach to manipulate
the genotype of prioritized putative causal AD risk variants that alter gene expression
or alternative splicing of mRNAs, focusing largely on genes implicated in phagocytosis
and lysosomal-autophagy function. Through isogenic comparisons of neurons, microglia, and
astrocytes, we propose to examine the molecular and functional effects of perturbing five putative
causal SNPs separately testing their cell autonomous and non-cell autonomous impact on cellular
function. Our hope is that this work may identify novel therapeutic points of intervention in order
to prevent or slow disease course in individuals with AD. This project will have a large overall
impact by providing a mechanistic interpretation of genetic variants associated
with AD susceptibility.

Public health relevance
The causal role of Alzheimer’s disease (AD) risk variants in neuronal or glial cells is unresolved. By combining genetic fine-mapping, CRISPR-genetic engineering, and human induced pluripotent stem cell models, we propose to test the molecular and functional impact of perturbing the genotype of AD risk alleles. We hope to find insights into the mechanism of disease initiation and progression in AD, in order to one day reverse the disrupted molecular pathways that contribute to this debilitating disorder.